Administration and Communication

The Program consists of three projects and 5 cores, distributed between 4 sites in Boston, all affiliated with Harvard Medical School. The Administrative Core will support all these sites with help in communications, meetings organization, web design and recruitment. It will support financial administration and purchasing for Projects 1 and 2 and Core B, and will interface with local grants management teams for financial administration of Project 3 and Cores C-E.